Novel strategies to mitigate cardiac damage and dysfunction following invasive pneumococcal disease

One-in-four adults hospitalized for community-acquired pneumonia (CAP) experiences a major adverse cardiac
event (MACE). Critically, individuals who experience MACE are 4-5 times more likely to die than those with
pneumonia alone. Hospitalization for CAP is also tied to a greater risk of MACE (up to 10-fold within 30 days of
hospitalization) and cardiovascular (CV)-associated death in convalescence for at least 5 years. Thus,
pneumonia damages the heart and this is linked to MACE and CV-associated death during and after
hospitalization. Of note, studies on Streptococcus pneumoniae (Spn), a Gram-positive bacterium and the leading
cause of CAP, have historically focused on events that occur in the respiratory and nervous systems. Indeed,
although Spn-mediated cardiac damage/dysfunction is now well-established clinical problem, no specific
treatment is available to combat this devastating condition. To address this unmet medical need, we will focus
on identifying potential mitigation strategies to alleviate the cardiac damage following pneumococcal disease.
Our preliminary studies have revealed the excessive recruitment of multiple components of the S100A8/9-
NLRP3-IL-1β signaling circuit in the heart of Spn-infected animals. Therefore, aim 1 will test the hypothesis that
the S100A8/9-NLRP3-IL-1β signaling circuit is critical to mediate Spn-induced excessive cardiac inflammation,
adverse remodeling, and dysfunction. These studies will be accomplished by employing a combination of mouse
genetic models (S100A9 and NLRP3 knockouts (KOs)) and pharmacological agents (S100A9 inhibitor
(Paquinimod, in vivo), and NLRP3 inhibitor (CY-09, in vivo)). Although macrophages (MΦs) are heterogeneous,
a distinction has emerged between circulating monocyte-derived C-C chemokine receptor 2+ (CCR2+) MΦs that
prolong inflammation (detrimental), versus tissue-resident or circulating CCR2- MΦs, which are critical to resolve
inflammation and promote healing (protective). Our preliminary studies revealed excessive cardiac recruitment
of proinflammatory CCR2+ MΦs in Spn-infected hearts, which persist in the myocardium even after antibiotic
clearance of the infection. Hence, Aim 2 will test the hypothesis that Spn promotes adverse cardiac remodeling
by excessive recruitment of proinflammatory CCR2+ MΦs. CCR2 KO mouse model and novel anti-CCR2
monoclonal antibody (MC-21) will be employed to determine whether inhibiting the CCR2+ axis attenuates the
Spn-mediated adverse myocardial remodeling. Thus, proposed studies will identify novel mechanisms by which
detrimental profibrotic and prolonged inflammation could be selectively targeted without hampering the
repairing/healing mechanisms. The human relevance of critical findings from the mouse model will be accessed
with blood samples from CAP patients. The interventional studies for mitigation approaches with the mouse
model will be further validated in the human cardiac tissue chip (heart-on-a-chip) model. We are confident that
accomplishing the proposed studies will put us in an ideal situation to carry out a modes clinical trial to alleviate
the cardiac burden of CAP patients.

Public health relevance
Streptococcus pneumoniae (Spn) induced community-acquired pneumonia (CAP) leads to adverse cardiac outcomes during bacterial infection and even months and years that follow. The mechanisms by which pneumonia can affect the long-term risk of CVD are poorly understood. Therefore, the proposed work has very high significance since it addresses a challenging set of cardiac problems faced by many CAP patients for which currently there are no specific treatments.